Platelet TSP1 Mediates Vascular Disease and pulmonary hypertension in Sickle Cell

DESCRIPTION (provided by applicant): This is an application for a K23 award for Dr. Enrico Novelli, a Hematologist, Assistant Professor in the Tenure Stream in the Department of Medicine and Director of the University of Pittsburgh Adult Sickle Cell Anemia Program. Dr. Novelli is establishing himself as an academic leader in the field of benign hematology with a specific focus on translational research in sickle cell disease and hemostasis. Dr. Novelli has prior extensive research experiences in hematology and has been successful in obtaining research awards for his studies on SCD. He has assembled a multidisciplinary team of mentors and advisors to guide his career towards independence and to assist with the completion of the research proposed in this application. This grant will be critical to achieve the following career objectives: (1) to develop expertise in laboratory methodologies crucial to the conduct of translational research in SCD; (2) to gain further in-depth knowledge of clinical trial design and biostatistics fundamental in the investigation of human disease; and (3) to become an expert in the vascular biology of SCD. He plans to complement his research activity with the completion of a Master of Science in Clinical Research sponsored by the University of Pittsburgh, with participation in scheduled training activities on grant writing and responsible conduct of research, and with attendance to international meetings in his areas of interest. By the end of the funding period of this K23 award, he will have several first-authored peer-reviewed publications and a critical mass of data that will form the core of an RO1 or other equivalent grant. The focus of this application is on the vascular biology of SCD. In SCD, mutant hemoglobin S polymerizes when deoxygenated, driving red blood cell (RBC)-dependent vaso-occlusion and hemolysis. These processes lead to platelet and hemostatic activation, pulmonary hypertension and vascular disease. Transgenic-knockout sickle (BERK) mice that express exclusively human α- and βS-globins mimic SCD in humans by displaying reduced NO bioavailability, impaired NO-mediated vascular reactivity and pulmonary hypertension. Recently, the platelet α-granule protein thrombospondin-1 (TSP1) was found to potently inhibits physiologic NO signaling, via binding to the cell surface receptor CD47. Preliminary data from Dr. Novelli now demonstrate that circulating TSP1 levels are increased in the plasma of patients with SCD. Preclinical studies supporting this proposal also show that the specific TSP1-CD47 ligand receptor interaction not only inhibits NO signaling in endothelial cells, but also increases reactive oxygen species (ROS) production and endothelin A (ETA) receptor expression in smooth muscle, both canonical vasoconstrictive and mitogenic pathological signaling pathways contributing to pulmonary hypertension. Extensive preliminary data using chimera cross transplantation systems confirm that CD47 is critical in the development of PH in the transgenic sickle cell mouse. These findings inform the grant's overarching hypothesis that during platelet activation in patients with SCD, increases in circulating plasma levels of TSP1, via binding to the CD47 receptor, disrupt pulmonary vascular endothelial NO production and stimulate smooth muscle ROS production and endothelin 1 signaling, which lead to pulmonary hypertension in murine models and human subjects with SCD. This grant will also explore the hypothesis that therapeutic disruption of the TSP1-CD47 ligand-receptor interaction will both prevent and reverse pulmonary hypertension in SCD. This hypothesis will be tested via the following aims: (1) to examine for the first time whether plasma from human subjects with SCD TSP1 levels in the plasma of patients with SCD disrupt the vasodilator/vasoconstrictor balance in endothelium and smooth muscle by inhibition of NO signaling and increasing ROS and ETA levels; (2) to employ unique mutant murine models to determine the role of circulating TSP1 and CD47 in SCD-associated vasculopathy and pulmonary hypertension, and test the therapeutic efficacy of blocking TSP1-CD47 to prevent/mitigate SCD-based pulmonary hypertension; and (3) to test TSP1 levels in several large cohorts of patients with SCD and explore the correlation of TSP1 with platelet activation, pulmonary hypertension and vascular disease. This proposal is strengthened by the complementary and rich tool set used to investigate the hypothesis, the vast resources available within the Vascular Medicine Institute, a state of the art facility within the University of Pittsburgh devoted to the study of vascular biology, and captures the pioneering work of Dr. Novelli's mentors in defining hemolysis in the pathophysiology of SCD (Dr. Mark Gladwin's lab) and the TSP1-CD47 nexus as an upstream regulator of NO signaling (Dr. Jeff Isenberg's lab). Definition of this pathway will therefore present a novel therapeutic target for the vascular complications of SCD.

Public health relevance
Project Narrative There is a critical need to elucidate the vascular pathology of sickle cell disease so that new therapeutic approaches can be developed for this orphan disease. The K23 funding mechanism will provide the candidate with a unique set of skills and expertise in the vascular biology of sickle cell disease, nitric oxide metabolism, measurement of oxidative stress and translation of research findings from bench to bedside. __SpecificAimsTextDelimiter__ Specific Aims: Sickle cell disease (SCD) is caused by the genetic inheritance of a mutated hemoglobin molecule (HbS) with a decreased solubility and a propensity to polymerize under low oxygen conditions. HbS polymers lead to hemolytic anemia and a pro-inflammatory state characterized by increased erythrocyte adhesion, vasculopathy and hemostatic activation. Intra-pulmonary sickling and infarction, thromboembolism, in situ thrombosis, and endotheliopathy secondary to chronic intravascular hemolysis are all pathogenic mechanisms that contribute to the development of vascular dysfunction and pulmonary hypertension (PH).13-15 PH remains chronic, progressive and fatal in adults with SCD, and is directly correlated to the severity of hemolytic anemia, as well as other established risk factors such as renal insufficiency, iron overload and thrombo-embolism.16-18 The development of PH in sickle cell patients is recapitulated in the transgenic- knockout sickle (BERK) mice that express exclusively human α and βS-globins.19-22 BERK mice not only develop endothelial dysfunction but also spontaneously develop PH.23-25 Platelet activation in patients with SCD has been associated with the severity of both hemolysis and degree of PH, suggesting a pathological link between platelet activation and PH.10 Prior studies indicate that the platelet α-granule protein thrombospondin-1 (TSP1) potently inhibits physiologic NO signaling and contributes to vascular disease, via binding to the cell surface receptor CD47,12 but this pathway has never been explored in SCD. In this proposal, the role of TSP1 as a major disease modifier in SCD will be evaluated. Specifically, I hypothesize that TSP1 binds to CD47 in the sickle cell pulmonary vasculature to cause endothelial and smooth muscle dysfunction and drive pathological pulmonary vascular remodeling and PH. Preliminary data demonstrates that circulating TSP1 levels are increased in the plasma of patients with SCD. In vitro studies supporting Aim 1 show that the specific TSP1-CD47 ligand receptor interaction not only inhibits NO signaling in endothelial cells, but also increases reactive oxygen species (ROS) production and endothelin A (ETA) receptor expression in smooth muscle, both canonical vasoconstrictive and mitogenic pathological signaling pathways contributing to PH. In Aim 2 our extensive preliminary data using chimera cross transplantation systems confirm that CD47 is critical in the development of PH in the transgenic sickle cell mouse. We test the effects of morpholino suppression of CD47 in this sickle cell mouse model, with new data showing significant amelioration of the severity of PH in SCD mouse models. The stated hypothesis and the following Specific Aims have never been tested in SCD, and explore new down-stream effects of the TSP1- CD47 pathway on ROS generation, pulmonary artery smooth muscle mitogenic responses, and the critical role of this pathway in SCD pathogenesis. The proposal draws upon my access to both large SCD patient registries, as the director of the adult SCD program, and my expertise with mouse chimera models: Aim 1. Bench: To test the hypothesis that high circulating plasma levels of TSP1 in patients with SCD bind to endothelial and smooth muscle CD47 to dysregulate the normal vasodilator/vasoconstrictor balance. Using human and CD47KO mice-derived endothelial and smooth muscle cell culture systems co- incubated with TSP1 or plasma from normal volunteers and patients with SCD, with and without immunodepletion of TSP1, we will assess the effects of plasma TSP1 on reducing NO signaling, increasing ROS production and upregulating the vasoconstricting ETA pathway. Aim 2. Pre-Clinical Translation: To test the hypothesis that CD47 knock-out improves endothelial dysfunction and reverses PH in the BERK mouse model of SCD. Using cross transplantation of the BERK mouse bone marrow into CD47KO mice to create chimeric animals with SCD on a CD47-/- background, we will determine the specific role of TSP1-CD47 interactions in the pathogenesis of PH in this model. In supporting experiments, BERK mice will be treated with a monoclonal blocking antibody against CD47 or a gene- suppressing CD47 oligonucleotide morpholino. Full hemodynamic and histologic assessment will be conducted at the end of the treatment period to demonstrate prevention or amelioration of vascular dysfunction and PH. Aim 3. Bedside Clinical Translation: To test the hypothesis that TSP1 is increased in SCD secondary to pathological platelet activation and is associated with markers of disease activity and pulmonary hypertension. Using our well-phenotyped cohorts of patients with SCD, we will determine if plasma TSP1 levels correlate with markers of platelet activation and clinical events. Multivariate analyses will be performed on the relationship between TSP1 and disease state. We will also evaluate correlations with vasculopathic complications such as cutaneous leg ulceration, functional status (six-minute walk distance and NT-pro-BNP), and echocardiographic indices (diastolic dysfunction, PH). These investigations although limited to association and risk assessment, will provide critical translational relevance to the studies performed in Aims 1 and 2. Completion of these aims will provide novel insights into the pathobiology of SCD by linking pathological platelet activation to impaired vascular function, via the intermediacy of TSP1. This work expands knowledge of how CD47 down-stream signaling can not only inhibit NO production but also increase vasoconstrictor production (ROS and ETA receptor). These proposed studies will extend my skill set in bench-to-bedside research, ranging from cell signaling, vascular biology, and pre-clinical transgenic models of vascular disease, to human epidemiology and clinical trials.